Identifying novel atheroprotective mechanisms

PROJECT SUMMARY/ABSTRACT
Atherosclerosis is a disease caused by cholesterol accumulation in the arterial intima. Since atherosclerosis
causes heart attacks and strokes, this disease is considered to be the leading cause of death globally. Hence,
finding more effective treatments for atherosclerosis may reduce deaths that are caused by heart attacks and
strokes. Increasing the removal of cholesterol from arterial intimal cells may be a possible approach for treating
atherosclerosis.
One type of arterial intimal cell that has been proposed to greatly influence atherosclerosis progression is
vascular smooth muscle cells. These types of cells can migrate from the arterial media into the intima and begin
internalizing intimal cholesterol. However, once vascular smooth muscle cells become cholesterol-filled, it is
thought that they lose the capacity to remove excess cholesterol through downregulation of the ABC-
transporters, ABCA1 and ABCG1. These two transporters remove intracellular cholesterol from cells by
participating in cholesterol efflux. ABCA1 and ABCG1 do not efflux cholesterol identically though, as they interact
with various cholesterol acceptors differently to mediate cellular cholesterol efflux. Furthermore, it is not currently
known whether ABCA1 and/or ABCG1 expression in vascular smooth muscle cells is atheroprotective, and if
increasing expression of these transporters may protect against atherosclerosis. The goal of this proposal is to
test whether ABCA1 and ABCG1 expression in vascular smooth muscle cells is atheroprotective.
This proposal has two Aims, with both Aims utilizing cell culture systems and atherogenic mice. One Aim will
robustly analyze the potential atheroprotective impact of ABCA1 expression in vascular smooth muscle cells by
using vascular smooth muscle cell-specific overexpression and knockout models. The second Aim will rigorously
assess the potential atheroprotective impact of vascular smooth muscle cell ABCG1 expression by employing
models that are either ABCG1 deficient or overexpress ABCG1.
The long-term objective of this proposal is to discover vascular smooth muscle cell ABC-transporter expression
as being atheroprotective. Succeeding in both Aims would accomplish this objective and demonstrate proof-of-
principle that increasing ABCA1 and ABCG1 expression precisely in vascular smooth muscle cells may be a
novel strategy for treating atherosclerosis.

Public health relevance
PROJECT NARRATIVE Public Health Relevance Atherosclerosis kills more people than any other disease and is caused by cholesterol accumulating in arteries. Removing excess cholesterol from vascular smooth muscle cells in arteries may prevent atherosclerosis. Our proposed studies will use strategies that alter cholesterol removal pathways precisely in vascular smooth muscle cells, which may lead to the development of effective atherosclerosis treatments.